Biostatistics and Data Analysis

ABSTRACT
Building on over 30 years of close collaboration between the Core Leader (Professor Maislin) and Program
Project Director (Dr. Allan Pack), as well as long-standing collaborations among other Project Investigators and
members of the Core, the Biostatistics and Data Analysis Core (Core B) will play a crucial role in this Program.
Primary responsibilities of the Core include to promote good scientific practice in the conduct of the research
protocols, to implement statistical and machine learning analyses relevant to each Project's aims, to adapt
methods or develop novel approaches where necessary, to collaborate with the Data Integration Core in data
collection, management and analysis, to provide expert statistical programing using specialized software, and to
ensure the fair, accurate, and unbiased publication of research findings from this Program Project.

Public health relevance
LAY NARRATIVE The Biostatistics and Data Analysis Core, or its equivalent, has supported sleep research at the University of Pennsylvania under the leadership of Greg Maislin, Adjunct Professor of Statistics in Medicine, since 1989. Members of the Core work collaboratively with faculty and investigators to ensure appropriate methods are used in the conduct of research proposals, directly supporting study design, data collection and quality assurance, statistical programming and analysis, dissemination of results, and manuscript and grant writing. The Core will leverage this expertise and dedication to sleep research in support of the individual Projects and overall Program.